Development of a socially connected exercise system for wheelchair users

Veterans who use wheelchairs are often prescribed physical activity (PA) in an effort to manage weight and
improve cardiovascular health and function however few wheelchair users are currently meeting the
recommended amounts of moderate to vigorous aerobic activity (3 times per week ~30 minutes per session).
There are many barriers to achieving ample PA including lack of transportation to PA facilities and programs,
social support, motivation and access to accessible fitness equipment and knowledgeable trainers. An
accessible, motivating, socially supported, and effective exercise option that wheelchair users can participate
in from home could help mitigate these barriers to engaging in routine PA. With the onset of the pandemic
came a wealth of home-based smart connected exercise devices and fitness apps that enable for interactive
video based instruction, virtual/augmented reality world exercise experiences, and integrated social networking
features (e.g. group exercise, leaderboards) for the able-bodied market. These applications have been found
to improve intrinsic motivation through social support and enjoyment in addition to PA levels and performance.
However, these technologies are largely exclusive of persons with disabilities due to the inability to use the
connected fitness equipment. Current upper-arm ergometers have limited internet connectivity. Handcycles
can be adapted to smart connected bike trainers for use in the home but they require a customized set up that
requires a difficult transfer and a lot of space. Therefore, we propose to develop a home-based, smart
connected upper-arm ergometer that would enable wheelchairs users to more easily and effectively participate
in video and virtual reality-based fitness apps that have social components and motivational features. The
specific aims of this study are: 1) to iteratively develop a prototype home-based, smart connected upper-arm
cycling trainer (ParaCycle) 2) verify the functionality of the ParaCycle through in lab testing with wheelchair
users; and 3) conduct a 6-week in-home pilot study with the refined ParaCycle prototype to evaluate its
functionality, safety, utility and device satisfaction. For Aim 1, we will develop ParaCycle in accordance with
engineering standards related to the manufacturing of connected fitness equipment and involving end users
and stakeholders in the design review process. In Aim 2, 15 wheelchair users will be tested on the setup and
use of the device (>68 on the System Usability Scale), the ability of ParaCycle to elicit moderate to high
intensity exercise (average session power between 76% and 87% functional threshold power), and a high level
of enjoyment (Physical Activity Enjoyment Scale > 100). For Aim 3, a 6-week in-home study will be conducted
with 10 wheelchair users to assess functionality (e.g. ability to maintain continuous communication with the
fitness apps and remotely transmit fitness data); safety (e.g. adverse events as a result of device use) and
utility (e.g. how often the device is used) and level of satisfaction.

Public health relevance
Physical activity levels among Veterans who use wheelchairs is very low despite the importance of PA in improving overall physical and mental health. Wheelchair users face many barriers to exercise above that of the general population including lack of transportation to PA facilities and programs, social support, motivation and access to accessible fitness equipment and knowledgeable trainers. Home-based fitness products involving access to live and on-demand video instruction and virtual reality applications have become widely popular and beneficial for increasing fitness and motivation among able-bodied individuals during the pandemic however they are not accessible or tailored to the needs of wheelchair users. Therefore, the goal of this project is to develop a home-based upper arm exercise bike that will be compatible with video based instruction and virtual reality real-world riding apps that offer social components and motivational features.